REMIT (Rescue Mitochondrial Therapeutics): Unlocking Broad-Spectrum Mitochondrial Rescuers

Project Summary
Founded in 2014, Perlara PBC was the first biotech company established as a Public Benefit
Corporation (PBC). Over the past decade, the company has pioneered the use of invertebrate
model organisms—such as yeast, worms, and flies—for drug repurposing to address rare
genetic diseases. Since 2022, Perlara has shifted its primary focus to the budding yeast
Saccharomyces cerevisiae. This model organism offers unmatched speed, cost-efficiency, and
suitability for studying inherited metabolic disorders, including congenital disorders of
glycosylation (CDGs) and mitochondrial diseases like Leigh Syndrome. Within just two years,
Perlara has developed a pipeline of 17 yeast-driven drug repurposing programs, each funded by
affected families and resulting, in most cases, in the identification of clinically actionable
compounds. Notably, the company’s flagship PMM2-CDG program has progressed from a
yeast-based discovery to a fully enrolled Phase III pivotal study (NCT04925960) in under five
years and with less than $5 million in funding. This program was advanced in collaboration with
Maggie’s Pearl, LLC, a family-led organization (https://www.maggiespearl.com/).
Building on the success of its yeast platform and targeting mitochondrial diseases, Perlara now
plans to screen 8,400 repurposable drugs and nutraceuticals using Yarrowia lipolytica, an
obligate aerobic yeast. By inhibiting specific complexes of the electron transport chain with
pharmacological agents, this novel screening approach will uncover therapeutic candidates
capable of restoring mitochondrial function. Promising compounds identified through these
screens will undergo validation in human fibroblast models, utilizing assays such as Seahorse
for mitochondrial function and RNA sequencing for transcriptomic profiling to inform clinical
outcomes.
The company’s commercialization strategy aims to combine clinical development pathways for
FDA approval with partnerships involving nutraceutical manufacturers and compounding
pharmacies. This approach will enable the direct-to-consumer availability of proprietary
combination therapies. Over time, the model anticipates cost reimbursement from insurers,
healthcare systems, and government programs, driven by the potential for system-wide savings.
Additionally, these therapies are expected to create broader economic benefits by allowing
caregivers to rejoin the workforce and empowering patients to lead more fulfilling and productive
lives.

Public health relevance
Project Narrative Mitochondrial diseases affect as many as 1 in 4000 people in the world, but there are only a handful of approved medicines for mitochondrial diseases. An economical, fast and proven yeast-driven drug screening platform will identify a pipeline of repurposable small molecules that restore mitochondrial function. Validation in human cell models will nominate drug candidates and reveal biomarkers that can be used as robust outcome measures in drug repurposing clinical trials.